Research Education Core

The Research Education Core (REC) of the Ponce Health Sciences University and Moffitt Cancer Center
Partnership has built an educational program that supports participants across the career continuum, preparing
them for basic or clinical oncology-related careers. The long-term goal of the REC is to increase the recruitment,
advancement, and quality of cancer research scientists and oncologists from our catchment areas while
advancing cancer research. Through ongoing interactions with all components of the Partnership, the REC’s
educational framework (2007-2022) has resulted in: 125 participants obtaining faculty, medical, or
industry/federal/academic positions with 30 in hematology-oncology clinical practice; completion of 137 research
rotations by PhD, MD or PsyD students; guidance of 22 Early-Stage Investigators (ESIs); and the creation of
new courses, clerkships, and robust seminar series. Leveraging our prior successes the REC strategy is
designed to jointly engage participants across career levels and institutes to create a lasting peer mentoring
network which will be accomplished under the following aims: Aim 1 engages undergraduate students from local
universities at both PHSU and MCC, eight total per year, in a new two-year-plus program with year-round
mentoring and research experiences combined with intensive summer research immersion to promote
knowledge of cancer research. Aim 2 establishes two-year post-doctoral scholarships at MCC for fellows to
support career success with a focus on cancer outcomes, and also establishes career development scholarships
for late-stage PHSU PhD students to support career enhancement activities and successful transition to postdoctoral training. Two rolling scholarship slots are available at each site. The scholarships are interwoven with training in enhancing communication and understanding between clinicians/researchers and community
members/patients, professionalism, scientific writing, and cancer outcomes to successfully promote a path
toward independence. Aim 3 addresses the need to increase the number of medical residents and medical
students entering an oncology career track. REC will facilitate the creation of the first urology residency program
in PR, enable surgical oncology training at MCC for two PR surgical residents per year, and immerse eight
medical students per year in a summer cancer research experience alongside PhD students. Aim 4 enhances
the career development of ESIs by providing individualized support for each ESI through collaborative
interactions, training on addressing cancer outcomes in our catchment areas, grant/scientific writing workshops,
career development activities, identifying networking opportunities, and tracking and evaluating ongoing
mentorship and sponsorship. In sum, REC trainees will gain cancer research experience through exposure to
Partnership projects and Cores. The REC outcomes will support the overall Partnership objectives by building
and strengthening trainee career pathways at critical career transition points, resulting in more oncologists and
research scientists.